Investigations of menin function in Ewing sarcoma

PROJECT SUMMARY
Pediatric cancers can be considered developmental disorders in which oncogenic drivers hijack normal
developmental programs to promote tumorigenesis. The scaffolding protein menin is essential for normal
development and, in human cancer, can function as a tumor suppressor or an oncogene, depending on
context. The diverse functions of menin are linked to its role in regulation of gene transcription via its
interaction with MLL histone methyltransferases, as well as with other context-dependent binding partners. In
MLL-rearranged leukemia (MLLr), protein:protein interactions between menin and MLL-fusion proteins drive
epigenetic activation of oncogenic transcription programs. A critical dependence of MLLr leukemia on these
interactions represents a unique therapeutic vulnerability and small molecule inhibitors of the menin:MLL
interaction are being developed for leukemia-directed therapy. Ewing sarcomas are mesenchymal tumors of
presumed stem cell (MSC) origin that are driven by EWS/ETS fusions, most commonly EWS/FLI1. EWS/FLI1
initiates sarcomagenesis by hijacking normal MSC differentiation. Importantly, menin plays an essential role in
early mesenchymal development, where it contributes to both lineage commitment and osteoblastic
differentiation. We have shown that menin is over-expressed by Ewing sarcoma relative to MSC and that loss
of menin results in loss of tumorigenicity. However, the mechanisms by which menin exerts its oncogenic
effects in these tumor cells remain unknown. Our preliminary data identified the serine synthesis pathway
(SSP) as a key downstream target of menin in Ewing sarcoma. We have confirmed that the SSP is hyper-
activated in Ewing sarcoma in a menin-dependent manner, and that inhibition of PHGDH, the rate limiting
enzyme in the SSP, results in profound loss of Ewing sarcoma viability, revealing a key dependence of Ewing
sarcoma on the pathway. Our data also suggest that EWS/FLI1 itself contributes to activation of PHGDH and
the SSP, and that transcription of a subset of EWS/FLI1-induced targets is dependent on menin. These data
collectively support the hypothesis that menin functions as an oncogenic hub in Ewing sarcoma. In this
proposal, we will investigate the mechanisms of menin function and test the innovative hypothesis that
EWS/FLI1 promotes tumorigenesis by hijacking menin-dependent transcriptional regulation. In Aim 1 we will
determine the mechanism by which menin activates the SSP and will elucidate the role of EWS/FLI1 in this
process. In Aim 2 we will define the key metabolites of the SSP that contribute to tumor maintenance in order
to determine why Ewing sarcoma cells are so dependent on this pathway. In Aim 3 will define genome-wide
transcriptional targets of menin in MSC and Ewing sarcoma and how they are impacted by EWS/FLI1. The
proposed studies will advance fundamental knowledge of the biologic underpinnings of Ewing sarcoma and
discover how EWS/FLI1 hijacks normal menin physiology to promote oncogenesis. It is goal that these insights
will provide opportunities to develop novel, and less toxic, menin-directed therapies for Ewing sarcoma.

Public health relevance
Project Narrative We have discovered that menin, a scaffolding protein that plays an essential role in early bone development, contributes to the pathogenesis of Ewing sarcoma, a bone and soft tissue tumor that peaks in adolescence. In this proposal we investigate the mechanistic basis by which menin promotes Ewing sarcoma tumorigenicity and define differences between menin function in normal and malignant development. The goal of these studies is to identify novel targets for Ewing sarcoma-directed therapies that will spare normal developing tissues.